SERVICE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. NAC provides service to the wide neuroscience community by making core technologies available. In addition to computation and software support and consultation, education and training in using the equipment and software are offered. All current released versions of software and data sets are available for download from our website.